SUBSTANCES IN BLOOD PRESSURE DYSREGULATION SYNDROMES

Under this protocol, patients with unusual forms of hypertension or hypotension including pheochromocytoma, carcinoid syndrome, systemic mastocytosis, autonomic insufficiency and other disorders of blood pressure regulation are studied.